INGESTION OF ZYMOSAN BY MACROPHAGES CYTOTOXIC EFFECTS

Phagocytosis is an important function in macrophages, and is essential for maintaining their tumoricidal and bactericidal functions. It is known that many reactive oxygen species (superoxide, nitric oxide (NO) + peroxynitride) are formed within and surrounding the ingested phagosome so as to destroy the ingested particle within. We have shown that addition of zymosan (in yeast extract) to macrophage stimulates a typical oxidative burst - with an increase in oxygen utilization as the zymosan/cell ratio is increased, oxygen consumption by these cells is inhibited. At the highest concentration of zymosan/cell (approx. 40) oxygen con sumption was very low (as shown by the rate of change in the linewidth of 15 N PDT). Experiments are underway to investigate whether production of nitric ox ide, in addition to having a toxic effect on the ingested particle/species, may be toxic to the cell if overproduced. Two important linesof investigation are apparent; to study the extent of binding of NO to ferrous protein complexes with in the cells (such as those enzymes essential to the respiratory chain), and als o to monitor the intrinsic metal ion EPR signal obtained from zymosan itself as it interacts with macrophages.